The genetic basis for age-related hearing loss in outbred mice

Summary
Age-related hearing loss (ARHL) has been linked to age-related cognitive decline. To date, no studies have
looked in detail at these two processes in a preclinical animal model. In this proposal we will, for the first time,
characterize the age-related changes in neural connectivity within the inner ear and brain in a premature aging
mouse model and explore the potential for two small molecules to prevent/regenerate these lost synapses.

Public health relevance
PROJECT LAY NARRATIVE The incidence of dizziness increases from 22% for adults between the ages of 65 and 69 to over 40% between the ages of 80 and 84 years, and fall-related injuries are highly correlated with reports of dizziness, constituting the sixth leading cause of death in the elderly and associated with a 20% mortality rate. We will identify the genes and pathways involved in the vestibular portion of the balance system of humans and aged mice, compare the genomic composition of human and mouse vestibular tissues, then test the hypothesis that the genes and/or pathways identified are critical to balance function. Our team will combine resources with the expertise of a neurotologist, otolaryngologist/data scientist, computational biologists, and neurogeneticists to identify genes and pathways underlying imbalance, leading to targeted therapies for prevention and treatment of imbalance and falls in the elderly.